CORE C--RECRUITMENT

Abstract This Core is responsible for conducting and/or assisting with recruitment for the three projects. The core will be responsible for maintaining a tracking data base that will provide information on the most useful recruitment strategies, for developing advertisements where appropriate, and for ensuring that recruitment procedures comply with requirements of the Institutional Review Boards.